Research Education Component

RESEARCH EDUCATION COMPONENT ABSTRACT
The Community Health and Aging in Native Groups of Elders (CHANGE) Resource Center for Minority Aging
Research (RCMAR) is a new iteration of the Native Elder Research Center (NERC) that has been continually
funded since its inception in 1998. We will continue this RCMAR’s mission to increase the diversity of
investigators conducting research with US Native populations, defined here as American Indian, Alaska
Native, and Native Hawaiian and Pacific Islander people. Our program has evolved to an intensive 18-month
program comprising a 12-month pilot study, a 3-day workshop, and a 6-month grant writing program. The
Research Education Component will be led by Clemma Muller, PhD, MS, at Washington State University. She
has been affiliated with RCMARs since 2002 and currently leads the Analysis Cores for 2 RCMARs. We feature
subcontract affiliations with Mentors: Valarie Jernigan, PhD (Choctaw), a former NERC Faculty and Scientist,
at Oklahoma State University; Scott Okamoto, PhD, a current RCMAR mentor, at University of Hawai’i at
Mānoa; and Mandy Fretts, PhD (Eel Ground First Nation), at University of Washington. These faculty
represent universities that employ many Native and other underrepresented minority (URM) early-stage
investigators whose participation as CHANGE Scientists will advance their careers and accelerate Native-
focused aging research at their institutions. CHANGE is highly responsive to the RFA’s requirements of recruiting
Scientists and providing Mentors from the parent or affiliated institutions, while concurrently accommodating the
real-world limitations presented by the highly-dispersed and relatively-small community of early-stage
investigators and senior faculty conducting Native-focused aging health research. Our Specific Aims are to: 1)
Provide intensive mentoring for 9 CHANGE Scientists, with customized support for career advancement and a
capacity-building “mentor pipeline;” 2) Facilitate professional development activities to build capacity for
leadership, Community Integration, community-based participatory research, networking, and collaboration; and
to foster an environment conducive to diversity, equity, inclusion, and accessibility, and inclusive excellence; and
3) Champion CHANGE Scientists’ efforts to obtain K- or R-series extramural funding, and provide services and
resources for research excellence that will accelerate progress toward tenure and promotion. A diverse scientific
workforce improves engagement, establishes trust with research participants from URM groups, ensures that
research is locally appropriate, promotes innovation, helps to avoid biased outcomes, and generates higher-
quality scientific publications. Personalized, culturally-informed training and access to URM role models are key
for successful URM training programs. Our approach reflects new literature on barriers and promotors of URM
faculty retention and embodies improvements identified by our former NERC Faculty and Scientists. CHANGE
Scientists will benefit from a well-informed, supportive environment and the participation and role modeling of
senior Native faculty – including RCMAR alumni – who conduct health research with Native community partners.